Identification and Development of Small Molecule Orthopoxvirus Inhibitors

The primary goal of this interagency agreement is to identify and develop small molecule inhibitors targeting orthopoxviruses.